IMMUNE RECOGNITION &PATHOGENESIS OF INFLUENZA VIRUSES: HIGH RESOLUTION CRYO SEM

Hemagglutinin molecule is a viral attachment protein. Another antigenic protein, the neuraminidase, is also on the surface of the virus particle, in conjunction with the hemagglutinin. The examination of influenza virus with high-resolution cryo-SEM would be extremely useful to reveal the conformational change of hemagglutinin.